Exploring Grief Through Social Determinants of Health Mechanisms Among Latinx Families in the US Who Are Living Through the Loss of a Child to Cancer: A Mixed Methods Study

ABSTRACT
Latinx children in the United States (US) are more than 50% more likely to die of their cancer diagnosis in
comparison to non-Latinx White children due to systemic inequities which arise from adverse social
determinants of health (SDOH). Latinx families in the US face several adverse SDOH including discrimination
based on race/ethnicity, language, or culture, and inequitable social structures that limit their access to various
resources, all of which affects their child’s risk of developing and dying from cancer and aggravate
bereavement and grief inequities among family members, including depression, anxiety, post-traumatic stress
disorder, and social isolation. Despite higher cancer mortality, there remains a striking under representation of
Latinx populations in the study of pediatric bereavement. Further, the identification of resiliency factors has
remained undiscovered because the experience of cancer loss in Latinx populations has not yet been explored
from a culturally and contextually grounded, strength-based perspective. The overall purpose of this study is
to explore the culturally grounded experiences and grief outcomes of Latinx families in the US who are living
through the loss of a child to cancer. This study will utilize a modified version of the Center for Latino
Adolescent and Family Health Framework of SDOH Mechanisms, that has been integrated with culturally
grounded grief concepts in a mixed methods design that integrates data from validated measures representing
the framework’s domains (n=60), with qualitative descriptive data from individual interviews (n=~20) with the
deceased child’s primary caregiver. The aims are to: Aim 1: To examine relationships among the domains of
the SDOH mechanisms of Latinx families in the US who are living through the loss of a child to cancer
including SDOH capital (healthcare access), SDOH processes (acculturation stress), contextual exposures
(social meaning-making), resiliency factors (Latinx culture) and critical grief outcomes (coping, mental health,
post-traumatic growth, continuing bonds) through self-reported measures. Aim 2: To elucidate the experiences
of Latinx families in the US who are living through the loss of a child to cancer in the context of SDOH
mechanisms (SDOH capital, SDOH processes, contextual exposures, resiliency factors, critical grief
outcomes) through in-depth, individual semi-structured qualitative interviews. Aim 3: To develop a
comprehensive understanding of how multilevel resiliency factors across the domains of SDOH mechanisms
(healthcare access, acculturation stress, social meaning-making, culture, critical grief outcomes) influence
adaptive grief outcomes among Latinx families in the US after the loss of a child to cancer by integrating data
from self-reported measures and qualitative interviews. The findings will enhance the understanding of the
mechanisms of inequities in pediatric oncology bereavement outcomes that can affect Latinx bereaved families
and inform the development of culturally grounded interventions to address them.

Public health relevance
PROJECT NARRATIVE Latinx families in the United States (US) are more likely to lose a child to cancer and experience inequities in bereavement and grief outcomes. This study will generate a comprehensive understanding of how the processes of adverse social determinants of health influence these inequities and how resilience could be leveraged to inform culturally and contextually grounded interventions for this population.